DEVELOPMENT OF DISUSE MUSCULAR ATROPHY

Humans at bed rest, immobilized, or in space travel, rapidly develop muscular atrophy. Using stable isotopes, muscle metabolism and the role of hormones in the atrophy process is examined.